Development of In Vitro Compression-Induced Rotator Cuff Injury Model: Aging and Inflammation in Tendon Degeneration

PROJECT SUMMARY
The long-term goal of this project is to understand age-related biological changes negatively impact
tendon mechanosensation and extracellular matrix remodeling. This application lays out a strategy to
understand mechanistically the consequences of an increased compressive loading environment on
tendon function, specifically as it relates to age-related rotator cuff degeneration. The central
hypothesis of the proposal is that the chronic inflammatory environment and other age-related
changes in tenocyte processes, combined with an increase in compressive loading due to poor
posture and musculature, may lead to tendon degeneration. We will first harness our in vitro culture
models along with incubator-housed controllable loading bioreactors to create compression-induced
tendon damage in tendon explants. Specifically, we are building the first-of-its-kind dual axis
mechanical loading bioreactor for tendon explant tissue to apply simultaneous tensile and
compressive loading to samples. Using this bioreactor, we will establish models of compression-
induced damage by varying loading duration (acute versus chronic) and maximum strain level (low
and high). We will then use these models to decouple the contributions of natural aging and
inflammation in the development of tissue damage. The project outlined in this application combines
fundamental basic research importance with translation directed toward the future diagnosis and
therapeutic treatment of early stage tendon degeneration. If successful, this work will fully decouple
the effects of inflammation and mechanical overload on age-associated tendon degeneration.
Furthermore, this model system can be used in the future to identify cellular pathways involved in
aging which alter the response of tenocytes to loading, and to identify anti-aging therapies which may
be more effective in preventing load-induced tendon damage in aged populations.

Public health relevance
PROJECT NARRATIVE Rotator cuff disease and injuries affect over half the population over the age of 60, causing significant pain, disability and decreased independence for the aging population. The overall goal of this proposal is to understand how the biology of natural aging influences the pathogenesis of rotator cuff degeneration in the case of compression-induced injury. Specifically, we will to identify age-related changes in the tenocyte response to compressive and tensile mechanical loading and decouple the roles of aging and inflammation in the progression of degenerative changes in the rotator cuff with the hopes of ultimately assisting clinical research in determining appropriate treatment and rehabilitation protocols for early stage tendon disease.